Education Core

The Education Core has two inter-related components: professional training for Center scientists, and outreach education to the public. We will provide comprehensive scientific training to scienfists at multiple levels in their educational process: undergraduates, graduate students, post-doctoral fellows (including clinical interns), and transitional scienfists who may have completed formal training but wish to re-specialize in areas of our expertise. The outreach component will provide timely and useful information to the general public, educational institutions and systems, and public policy organizations. These two components will be conducted in concert with one another and each will inform the other to create a truly integrated and meaningful educational program.

Public health relevance
Smoking and nicotine addiction represent two of the most insidious health problems in the worid today. The activities of the proposed Education Core will markedly enhance both the training of front-line scientists in these fields, and will promote public understanding of the research related to these very important health related topics.